Pilot multisite randomized controlled trial of yoga to reduce depression inadolescents

PROJECT SUMMARY
Even before the onset of the COVID pandemic, adolescent depression has been increasing, and health dispar-
ities and disparities in access to treatment have continued to widen. Thus, there is a clear need for innovative,
accessible treatments for depressed adolescents, including treatments that do not rely on a limited pool of child
and adolescent health providers. Yoga-based interventions (YBIs) have shown promise for adult depression.
Several attractive aspects of yoga include its: 1) availability throughout the U.S.; 2) accessibility via online clas-
ses; 3) independence from an overburdened mental health care system; and 4) generalizability--yoga students
state that they use mindfulness and breathing practices to cope with stress in everyday life. Funded by a
NCCIH R34, we developed a YBI for depressed adolescents, and demonstrated that this in-person program
was acceptable and feasible in a small sample (n=11) of depressed adolescents as well as in a pilot RCT
(n=42) of YBI vs. an existing evidence-based treatment, group cognitive-behavioral therapy (gCBT). The RCT
classes were initially in-person, but we migrated to synchronous online classes due to COVID-19. In the RCT,
participants within each study arm showed decreased depression symptoms and increased self-compassion
over time. Most a priori feasibility and acceptability targets were met (e.g., recruitment, retention, expectancy,
satisfaction, credibility, attendance, and adherence). However, participants did not engage in home (outside-of-
class) practice at the targeted rate. Thus, in the present proposal we have modified our protocol to provide an
opportunity for twice-weekly supervised yoga practice (one in-person class on the weekend, and one virtual
class midweek). Our prior pilot trial was based at only one site (Providence RI) with one primary YBI instructor
and two gCBT leaders. Multiple sites and instructors/leaders, and recruitment of a more racially and ethnically
diverse sample, will be important to demonstrate generalizability and to enhance effectiveness. We now pro-
pose to conduct a two-phase multi-site feasibility trial. Phase 1 (n=20) will focus on increasing accessibility and
feasibility of YBI for particular groups of adolescents. We will conduct individual interviews with teens who were
less represented in our pilot trial (African-American/Black, Asian American, and male adolescents) to gain their
feedback on yoga based interventions, with a focus on increasing accessibility and feasibility for adolescents
with these identities. Phase 2 (n=128) will be a pilot RCT of YBI vs. gCBT at two geographically distinct sites:
Boston, MA and Columbus, OH. Given the rising prevalence of adolescent depression and the existence of
established, efficacious group treatment for depression (i.e., group CBT), we determined that a non-inferiority
trial represented the most ethical way to proceed. We will incorporate lessons learned from this study to further
refine study materials and create a template for onboarding multiple future sites. This project will prepare us to
conduct a multisite, adequately powered, non-inferiority RCT of YBI vs. gCBT in depressed adolescents.

Public health relevance
PROJECT NARRATIVE Even before the onset of the COVID pandemic, adolescent depression has been increasing, and health disparities and disparities in access to treatment have continued to widen. Yoga-based interventions, shown to be effective in treating depression in adults, may be promising in adolescents as well, thus providing an alternative to the already burdened mental health care system. We propose a multisite pilot trial in preparation for an adequately-powered multisite non-inferiority trial of yoga-based intervention vs. group cognitive- behavioral therapy for adolescents with mild to moderate depression.